CORE--BIOMODEL

This scientific core with Dr. Schreiber as director will be responsible for services that are common to all projects within the program. All core services will be requested by requisition through Dr. Schreiber who will approve such requests. Centralization of these services will lead to both procedural efficiency as well as cost efficiency The core will be responsible for 1)isolation, culturing and distribution of cell cultures and reagent preparation for cell cultures 2) fixing, embedding, sectioning and mounting of cell and tissue samples 3) performing in situ hybridizations, and 4) assisting in developing transgenic/knock out mice. In addition, 5) confocal laser scanning microscopy (CLSM) which will be used by all projects, will be performed by the individual investigators but it will be paid for by the core which will also offer CLSM consulting services and 6) the core will play a major role in collaborative experiments between projects. Below, each core service is described a number including a brief description of core facilities and personnel, which are detailed further on the appropriate forms.